Administrative and Analysis

Core A, the Administrative and Analysis Core, will be responsible for overseeing the coordinated functioning of the three interrelated projects. This will be accomplished through regular updates of patient accrual and sample collection, through bimonthly conference calls, a yearly meeting with the Scientific Advisory Panel, and an additional yearly meeting of the Project Leaders when they co-attend a national meeting. Core A will have centralized storage of data accumulated for individual subjects and also coordinate the shipping of samples for the various analyses. Finally, Core A will work with the UNC Biostatistics Core to carry out analyses.

Public health relevance
Core A will function to maintain an integrated effort among the Project Leaders and their staff. In this way maximum benefit will be realized from this multidisciplinary approach.